Investigating the combined role of APOE4 and ketogenic diets in Alzheimer's disease

Abstract Diet and nutrition influence our cognitive abilities, how our brains age, and vulnerability to
neurodegeneration. However, the interaction of diet with the human brain is complex and influenced by every
person’s unique genetic composition. Clinical studies found that ketogenic diets and supplements improve
cognition and protect against Alzheimer's disease (AD) in most individuals but have no beneficial effect on
individuals with the strongest genetic risk factor for AD, APOE4. How APOE4 interacts with diet at the cellular
and molecular level to influence AD is unknown. The primary metabolite of ketogenic diets beta-hydroxybutyrate
freely passes across the blood-brain barrier into the human brain where it is converted to acetyl-CoA. Our data
demonstrate that cholesterol transport is impaired in APOE4 glia leading to intracellular cholesterol accumulation
which triggers inflammation, AD pathogenesis, and cognitive decline. As a compensatory mechanism to impaired
cholesterol trafficking, APOE4 glia upregulates cholesterol biosynthesis, which uses acetyl-CoA to generate
cholesterol. We hypothesize that impaired cholesterol trafficking and upregulation of cholesterol
biosynthesis in APOE4 glia adversely interact with high-fat/ketogenic diets to exacerbate and accelerate
AD pathogenesis. We established methods to mimic ketogenic diets in vitro. This revealed in APOE4 glia
ketones increase aberrant intracellular cholesterol deposits and promote neuroinflammation and
hypomyelination. We developed an in vitro model of human brain tissue that contains all the major cell types and
tissues including cerebrovasculature, neurocircuits, myelination, and neuro-immune cells. Aim 1 will employ this
system (miBrain) to further investigate the interaction of APOE genotype with high-fat/ketogenic diets and its
contribution to AD pathogenesis in human brain tissue. Using transcriptomic and biochemical approaches we
will discover the underlying mechanisms that we will modulate via chemical and genetic approaches to identify
therapeutic targets for promoting beneficial APOE4-diet interactions. We will complement this with studies in
APOE3/3 and APOE4/4 humanized mice in Aim 2 to mechanistically dissect the interaction between APOE
genotype and high-fat/ketogenic diets at the organismal level. Together aims 1 and 2 will provide holistic insight
into the peripheral and central interactions of APOE4 with ketogenic diets. Several other AD risk variants also
have functional roles in cholesterol and lipid homeostasis. We further hypothesize that cholesterol
dysregulation and its interaction with diet is a central pathogenic mechanism of AD. In Aim 3, we will
investigate using isogenic human brain tissue generated from iPSCs harboring genetic risk factors in SORL1,
TREM2, ABCA7, and APOE. We will determine how each risk variant interacts with ketogenic diets to influence
pathogenic outcomes in AD. Collectively, this study will pioneer approaches and technology that will deliver a
detailed molecular understanding of the interactions between genetics, diet, and neurodegeneration opening
avenues to genetically informed therapeutic and diagnostic opportunities.

Public health relevance
Project Narrative Alzheimer’s disease (AD), the most common neurodegenerative disease, affects 1 in 8 people older than 65 in the US and arises through unknown genetic and environmental mechanisms hindering the development of effective therapeutic strategies. We recently discovered that APOE4, the strongest genetic risk factor for AD, alters cholesterol homeostasis in the human brain, which likely adversely interacts with high-fat/ketogenic diets to accelerate AD pathogenesis. Combing innovative in vitro models of the human brain with in vivo mouse studies we will gain an in-depth mechanistic understanding of how APOE genotype interacts with diet to modulate outcomes in AD that will identify potentially non-invasive, genetically targeted therapeutic and diagnostic strategies for AD and related dementias.